Research Education Core

Disparities in educational attainment are more pronounced at each successive level, with 0.4% AIAN
enrollment in graduate STEM programs in 2021.2 Consequently, most scientists and health professionals
working with tribal communities are not representative of the communities they serve. The Partnership for
Native American Cancer Prevention (NACP) Research Education Core (REC) is actively improving this
landscape. By cycle 3, we showed evidence of AIAN trainees transitioning to graduate programs. Most
recently, cycle 4 trainees who were undergraduates in cycles 1 and 2 advanced to post-doctoral fellowships,
faculty positions, and clinician roles. We have also expanded our capacity to train more undergraduates
(N=146) in the current cycle and accelerated degree attainment; 73 graduate degrees were completed by
AIAN students in this cycle alone. The number of doctoral degrees attained now exceeds that of the prior 3
cycles combined. Thus, NACP has positioned our institutions as national leaders in AIAN education. NAU
leads the nation in undergraduate Public Health degrees and UA leads the nation in AIAN conferred doctoral
degrees.3-5 These successes are due in large part to the innovative approach to training embedded in
indigenous perspectives that we have honed with our AIAN faculty, students, and Community Advisory Board
(CAB). We have demonstrated that wrap-around support of students, including a “web” of mentors and
activities provides a culturally appropriate and highly effective environment for recruiting and retaining AIAN
students.6 Activities focus on enhancing students’ research skills by providing curricular programming and
hands-on mentored cancer research, complemented by career development planning and a wide range of role
models at both institutions. This mature REC program will expand across the Four Corners Region (AZ, CO,
UT, NM) to allow us to share more broadly our training and mentoring approach and increase the network for
student placement. We will embrace the two-eyed seeing paradigm as we expand the web of support which
will allow us to “see from one eye with the strengths of Indigenous knowledges and ways of knowing, and from
the other eye with the strengths of Western knowledges and ways of knowing”.7
Aim 1. Provide two-eyed seeing research education to diversify the workforce and improve the
capacity of UACC and NAU to develop AIAN cancer disparities research.
Aim 2. Increase AIAN student progression to graduate degrees and cancer-related careers by
providing uniquely integrated career development, mentorship, and networking activities.
Aim 3. Increase reach of the novel AIAN cancer health disparities research education and career
development program by establishing partnerships with AIAN serving colleges/universities and
Comprehensive Cancer Centers in the Four Corners Region.